Using SMART Design to Identify an Effective and Cost-Beneficial Approach to Preventing OUD in Justice-Involved Youth

SUMMARY/ABSTRACT
Youth involved in legal systems (YILS) are a vulnerable population with high rates of substance use and
overdose. Due to forced abstinence and consequent lower tolerance rates, the risk of overdose is 50 times
higher for incarcerated persons than the general population in the first two weeks after release. Nationally,
commensurate with the rise in frequency of illicitly produced fentanyl and other synthetic opioids, adolescent
overdose risk is increasing dramatically. Risk factors are also changing. Previously, prior use of highly potent
opioids and opioid or polysubstance use disorder were critical risk factors for adolescent/young adult overdose.
Currently only one in three youth that fatally overdoses has used opioids previously. In the Washington State
Department of Children, Youth, and Families Juvenile Rehabilitation (DCYF JR) system almost 1 in 3 youth in
our state-run facilities qualify as having opioid use disorder, and 58% of youth screened for substance use
disorders indicate that they have overdosed non-fatally at some point in the past. We seek to conduct a mixed
methods study to triangulate identification of modifiable overdose risk factors for YILS, develop strategies to
measure this risk, and develop and test a multilevel intervention to reduce this risk. We anticipate that a
combination of education, proven harm reduction strategies, and strategies to increase behavioral motivation
will be the most effective way to reduce overdose risk amongst incarcerated youth. Although this proposal is
focused on a specific high-risk population (incarcerated youth), we will develop overdose prevention strategies
that can be replicated in other populations, addressing one of our nation's most critical public health concerns.
In Aim 1 we will conduct qualitative individual semi-structured interviews with youth with exposure to overdose
(20-30); internal stakeholders such as staff and medical personnel (10-15); and external stakeholders with
research or policy expertise (5-10). In Aim 2 we will conduct a cross-sectional assessment of administrative
DCYF JR data to identify modifiable risk reduction factors associated with prior overdose event. In Aim 3 we
will develop multilevel preventive intervention data from prior aims. We anticipate including educational
campaigns/initiatives, naloxone and fentanyl test strip distribution, motivational interviewing to develop
overdose prevention goals and enhance motivation to carry out these goals, and text messaging reminder
components. We will test specific components of the intervention in need of refinement with 20 DCYF JR
youth, in anticipation of a future randomized controlled trial (RCT). Finally, we will explore data linkages
between DCYF JR and other administrative data systems to determine if it is possible to predict which
system(s) youth experiencing fatal or near fatal overdose are most likely to have interacted with in the 2
months prior to the overdose event. This proposal is aligned with NIDA's HEAL initiative and strategic plan and
will reduce overdose risk among our nation's most vulnerable youth.

Public health relevance
PROJECT NARRATIVE Overdose risk is incredibly high and increasing among incarcerated youth, particularly right after release. In this supplement we will design a multilevel overdose intervention that includes education components for youth, staff and families; provision of naloxone and fentanyl test strips; text messaging; and a brief motivational interviewing (MI)-based intervention designed to increase motivation to use proven overdose reduction strategies. We will then theater test key components in anticipation of a future randomized controlled trial.